REGULATION OF SKELETAL MUSCLE AND ADIPOSE METABOLISM BY INSULIN ACTION ACTION

This research examines the effect of hyperinsulinemia on protein phosphorylation using the euglycemic insulin clamp method. After baseline samples are obtained, insulin will be infused into the antecubital vein for 120 minutes. Glucose will be monitored every 5 minutes and glucose infusion adjusted accordingly. At the end of the study a muscle biopsy from the quadriceps muscle will be done.